Development of an UNC13A antisense oligonucleotide treatment for ALS and FTD

Development of an UNC13A antisense oligonucleotide treatment for ALS and FTD
Project Summary
Background: In 97% of ALS cases, and roughly half of FTD cases, TAR DNA-binding protein 43 (TDP-43) is
lost from the nucleus to the cytoplasm, where it forms into aggregates. A major function of TDP-43 in the
nucleus is to repress cryptic exon (CE) inclusion during RNA splicing. Recent studies have shown that a CE is
included in UNC13A mRNA when TDP-43 is depleted from the nucleus of neurons resulting in a loss of
UNC13A protein. UNC13A single nucleotide polymorphisms (SNPs) are among the strongest hits associated
with ALS and FTD in human GWAS studies. The CE is located in the same intronic region as the primary risk
SNP. The risk SNP exacerbates the UNC13A CE inclusion - ALS / FTD patients with both risk alleles have
more CE inclusion than patients with one risk allele, who have more CE inclusion than patients with the
non-risk alleles. Similarly, risk SNP carriers have a dose-dependent reduction in survival. This additive risk
strongly suggests that targeting UNC13A to suppress the CE inclusion could have a substantial therapeutic
benefit. Since nearly all ALS patients have TDP-43 pathology, such a treatment would benefit them and not be
limited to SNP carriers. UNC13A plays a critical role in synaptic transmission and is essential for synaptic
vesicle release at most excitatory synapses and neuromuscular junctions. Among all the genes known to be
dysregulated by the loss of TDP-43 from the nucleus, only UNC13A has such strong genetic validation. Altered
STMN2 expression in the context of TDP-43 depletion is a hallmark of ALS / FTD, yet no link between ALS
risk and STMN2 variants has been established. Thus, UNC13A targeting treatments should be prioritized for
rapid advancement into clinical proof of concept studies.
AcuraStem’s mission is to identify targets that rescue multiple forms of ALS / FTD. Thus we have
established patient-specific ALS / FTD disease models of both genetically defined and sporadic diseases. We
show in these models that cortical neurons derived from an ALS patient with the risk SNP have more UNC13A
CE inclusion than neurons derived from ALS patients with non-risk alleles. When we depleted TDP-43 in
patient-derived neurons using short interfering RNAs (siRNA) it induced a robust inclusion of CEs and reduced
normal UNC13A mRNA and protein levels across many patient lines. Antisense oligonucleotides (ASOs) are
an attractive approach for genetic targets in the CNS like UNC13A with several successes, including nusinersen
for spinal muscular atrophy (SMA) and tofersen, soon to be approved for SOD1-ALS. We used our proprietary
ASO design platform to synthesize >125 ASOs and identified several novel ASO sequences that potently
blocked CE inclusion and restored UNC13A mRNA and protein levels. AcuraStem is uniquely positioned with
potent UNC13A ASO candidates that can be advanced towards the clinic for ALS and FTD.
Objectives & Impact: This Direct to Phase 2 project aims to optimize these candidates and identify a bona fide
development candidate for advancement in investigational new drug (IND)-enabling toxicity studies. This
project involves collaborating with the Jackson Laboratory to characterize a new human UNC13A TDP-43 ALS
/ FTD mouse model that will be essential for the field. This project has a high probability of commercial success
because there is a dearth of disease-modifying treatments in development that could work for the sporadic ALS
and FTD population, a large unmet need and commercial opportunity.

Public health relevance
Development of an UNC13A antisense oligonucleotide treatment for ALS and FTD Project Narrative Amyotrophic lateral sclerosis (ALS) and frontotemporal dementia (FTD) are complex diseases that result from many diverse causes. While there are currently no drugs that slow the progression of ALS or FTD, most of the new promising therapeutic strategies are focused narrowly on modifying the specific genetic mutations known to cause disease, however these treatments won’t work for the vast majority (>80% in ALS) of patients for whom the genetic cause of their disease is not known. Therefore, AcuraStem’s focus has been to develop treatments that can work for all ALS and FTD patients, including those for whom the genetic factors driving their disease have yet to be discovered - a large population with urgent unmet need.